Epigenetic Alterations and Targeted Therapies in North American ATLL

PROJECT SUMMARY/ABSTRACT
Adult T-cell leukemia/lymphoma (ATLL) is a disease of malignant CD4+ T cells that develops in human T-
lymphotropic virus-1 (HTLV-1) carriers. The 3-yr overall survival is an abysmal 25% even when managed with
the most aggressive chemotherapy. No outcome-changing targeted treatment currently exists. Thus, improved
understanding of pathogenesis and novel therapeutic strategies are urgently needed. We and others have shown
that ATLLs diagnosed in the Japanese (J-ATLL) and North American (NA-ATLL) patients have very different
clinical behavior, with the North American variant characterized by a higher rate of chemo-refractory disease and
worse prognosis. Recently, we performed the first targeted exon sequencing analysis in 30 patients seen at our
center and discovered significantly more mutations in genes controlling epigenetic modifications and fewer
mutations in the TCR/NF-kappaB signaling pathways than the Japanese ATLLs. Strikingly, the frequency of
EP300 mutations in our patient cohort (20%) was about 4 times that seen in the Japanese cohort (5.7%). One
of the transcription factors that can be acetylated by p300 is BCL6, a transcription repressor that critically controls
many functional aspects of mature B and T cells. We have discovered for the first time that BCL6 is expressed
in primary ATLL samples and ATLL cell lines. Interestingly, NA-ATLL cell lines are notably more sensitive than
J-ATLL cell lines to BCL6 inhibition. Additional experiments suggest that in NA-ATLL cells, BCL6 plays an
essential role enabling survival of NA-ATLL cells as they cope with elevated DNA replication stress during S-
phase of the cell cycle. Supporting the concept that the S-phase is an Achilles’ heel of NA-ATLL cells, these cells
but not the J-ATLL cells are exquisitely sensitive to a PARP inhibitor, Olaparib. These findings support our
working hypothesis that dysregulated epigenetic program is a central feature of NA-ATLL biology and that
attenuated p300 activity combined with a unique role of BCL6 in S-phase programs provides a novel opportunity
for therapeutic targeting. The following three specific aims are proposed to test this hypothesis.
Aim 1. Elucidate the mechanisms by which p300 regulates chromatin and gene expression in NA-ATLL.
Aim 2. Characterize the roles of p300 and BCL6 as regulators of DNA replication program and genome stability
in NA-ATLL.
Aim 3. Determine the mechanistic basis of PARPi sensitivity and design therapeutic strategies to target the S-
phase vulnerabilities of NA-ATLL.

Public health relevance
PROJECT NARRATIVE Adult T-cell leukemia/lymphoma (ATLL) is an extremely aggressive mature T-cell malignancy with limited treatment options. As such, improved understanding of pathogenesis and novel therapeutic strategies are urgently needed. Based on our preliminary studies, we hypothesize that mutations in an epigenetic modifier, EP300, and expression of a transcription factor, BCL6, cooperate to cause abnormalities in gene expression and DNA replication. In this project, we will carry out mechanistic studies to test this hypothesis, and evaluate the efficacy of PARP inhibitor-based therapy in novel preclinical models of ATLL.